Modeling and Analysis of Roles of Yeast Sphingolipids

DESCRIPTION (provided by applicant): There has been a recent explosion in the study of lipid mediated signal transduction and cell regulation. The over-riding paradigm has evolved from a reductionist approach and has focused on modular signaling whereby one stimulus regulates one enzyme resulting in the generation of one active molecule. However, the complexity of lipid metabolism far exceeds a simple collection of individual signaling modules such that one agonist may regulate several enzymes or the bioactive product of one enzyme (e.g. ceramide) may serve as a substrate for another enzyme generating a different bioactive molecule (such as diacylglycerol or sphingosine). Thus, we hypothesize that the complexity of lipid metabolism serves to provide a highly regulated and coordinated network of bioactive molecules with distinct and overlapping functions. This network then serves to integrate and coordinate complex responses of cells to various agents and environmental stimuli. This proposal will test the specific hypothesis that the sphingolipid sub-universe of cell regulation in S. cerevisiae constitutes a relatively discrete domain that allows the elucidation of biochemical regulation as well as integrative approaches. We propose that a combined reductionist and integrative mathematical and systems biology approach generates novel insights into lipid-mediated cell regulation and allows the dissection of specific pathways mechanistically and functionally... Thus, we aim to 1. Develop an integromics approach in order to dissect specific sphingolipid-mediated pathways in S. cerevisiae in response to specific perturbations of sphingolipid metabolism;2. Develop an advanced model of yeast sphingolipid metabolism that focuses on distinguishing individual ceramide species;and 3. Establish specific pathways of sphingolipid-mediated cell regulation. These studies will lay the groundwork for a "global" model of sphingolipid metabolism in which we may be able to predict specific metabolic and transcriptional responses that are regulated by individual sphingolipids. Subsequently, such an approach may allow us to predict the overall genetic response to a specific "configuration" of sphingolipid levels. This model system could then serve as a conceptual and practical platform to extend our hypotheses to other lipid classes, followed by other aspects of regulated metabolism (metabolomic level). Such approaches will prove critical in understanding the intricate, multi-level regulation of human pathobiology where bioactive lipids play key roles in such diseases as diabetes, neurodegeneration, cancer, and inflammation. PUBLIC HEALTH RELEVANCE: The metabolism of lipids is very complex yet it is critical as many lipids are functional molecules that affect the function of the cell and the body, and are involved in diseases such as diabetes, neurodegeneration, cancer, and inflammation. We have assembled a team of biochemists, molecular biologists, mathematical modelers, and system biologists in order to define novel approaches by which we can organize our knowledge on lipid metabolism and enable research that deciphers the function of individual lipids.

Public health relevance
The metabolism of lipids is very complex yet it is critical as many lipids are functional molecules that affect the function of the cell and the body, and are involved in diseases such as diabetes, neurodegeneration, cancer, and inflammation. We have assembled a team of biochemists, molecular biologists, mathematical modelers, and system biologists in order to define novel approaches by which we can organize our knowledge on lipid metabolism and enable research that deciphers the function of individual lipids.